Acquisition of an automated phase and fluorescence microscope for Cornell BRC Imaging Facility

Project Summary/Abstract
Though NIH researchers at Cornell University (Ithaca campus) are fortunate to have access to a handful of high-end
advanced microscopies (confocal, multiphoton, super resolution, light sheet), they lack a workhorse inverted microscope
that is broadly available for experiments requiring low to medium magnification. This proposal describes a request for a
Keyence compact microscope with phase contrast and fluorescence capabilities, an automated stage and a stagetop
incubator. The microscope supports timelaspe imaging, multi-position imaging, tiling, and imaging in multiwell plates and
flasks. It will be managed within the Imaging Facility as part of Cornell’s Biotechnology Resource Center (BRC). Data
management, scheduling and billing will be accomplished using already established BRC infrastructure. The microscope
will be available to all researchers on and off campus, and will specifically advance NIH-funded research programs focused
on tissue development, immunity, cancer, and biophysical signaling and communication.

Public health relevance
Project Narrative This proposal describes a request for a workhorse microscope with fluorescence and phase contrast imaging to be managed in an imaging core facility at Cornell University. The microscope will support a diverse group of NIH-funded researchers investigating biological principles of tissue development, immunity, cancer, and related biophysical signaling processes.